The Role of Stromal Autophagy in Cutaneous Melanoma

Project Summary
Melanoma is a highly aggressive cancer with a rising incidence and good therapeutic options exist for
only a subset of patients. Recent studies have shown that treatment with an autophagy inhibitor can
improve outcome for melanoma patients. Recognizing the importance of interactions between cancer cells
and the host, we chose to investigate the role of autophagy in the stroma.
We discovered a new connection between the metabolic/autophagic state of the host, and the
immune response to a tumor. We found that the host fibroblast-rich stroma adjacent to a melanoma have
higher levels of autophagy marker LC3 than cells distant from the tumor. Using co-culture models, we
discovered that cancer cells induce autophagy in co-cultured fibroblasts in a TGF-β-dependent manner.
Orthotopic melanoma allografts showed dramatic growth reduction in genetically-engineered mice in which
autophagy protein Atg7 was inactivated in the entire animal, or only in fibroblast specific protein 1 (FSP1)-
expressing cells, which includes fibroblasts and immune cells. Tumors grown in Atg7-deficient hosts had
lower levels of proliferation and higher levels of apotosis than tumors hosted in control mice. We conclude
that Atg7 expression in the host plays an important role in supporting tumor progression.
To understand the mechanism through which host Atg7 inactivation affects tumor growth, we performed
RNA-Seq analysis of tumors harbored in Atg7-inactivated and control mice and discovered a gene
expression signature of inflammation. Analysis of cytokines in the plasma and T cells of Atg7-deficient mice
revealed higher levels of Th1 type cytokines and no change in Th2 type cytokines. Memory CD4+ and CD8+
T cells from Atg7-deficient mice transitioned from naïve to effector states. Tumor infiltrating lymphocytes in
Atg7-deficient mice contained higher levels of CD8+ T cells than in control mice. Treatment with antibodies
that deplete T cells resulted in larger tumors in Atg7-deficient mice when tested in the whole body
conditional knockout model or in mice with FSP1-specific autophagy inactivation. We have therefore
discovered a new mechanism regulating the immune response to tumors.
We will investigate the role for additional cell types in anti-tumor immunity in Atg7-deficient mice, and the
role of Atg7 in anti-tumor and anti-antigen effector responses. We will test whether small molecule
autophagy inhibitors also induce anti-tumor immunity and whether autophagy inactivation sensitizes mice to
immune checkpoint inhibitors. We will also test whether the levels of host autophagy in specific cell types
correlates with the extent of immune cell infiltration into melanomas in patient samples. We anticipate our
findings will suggest new approaches for activating a patient's immune response to fight cancer.

Public health relevance
Project Narrative We discovered that cancer cells induce autophagy in surrounding cancer-associated fibroblasts, and that loss of autophagy in the tumor host results in activation of an immune response against a tumor. We will investigate the cell and molecular basis for the anti-tumor immune response in autophagy-deficient mice and test our findings in clinical melanoma samples. We will also determine whether treating a host mouse with small molecule autophagy inhibitors can phenocopy the anti-tumor immunity observed with genetic Atg7 inactivation and enhance the effectiveness of immune checkpoint inhibitors.